NCDA&CS Animal Feed Program Regulatory Program Standards Maintenance and Mutual Reliance Initiatives

Project Summary/Abstract – Overall
Project Title: NCDA&CS Animal Feed Program Regulatory Program Standards Maintenance
and Mutual Reliance Initiatives
Overall Project Description: The North Carolina Department of Agriculture & Consumer
Services, Food and Drug Protection Division, Animal Feed Program (NCAFP) will support a
nationally integrated food safety system through participation in projects described in this
funding announcement to include maintaining implementation of the Animal Food Regulatory
Program Standards (AFRPS) and Mutual Reliance initiatives in coordination with FDA.
Overall Project Objectives: The NCAFP will maintain implementation of the AFRPS, which is
recognized as a critical element to creating a national, fully integrated food safety system. The
NCAFP further commits to contribute to the continuous improvement of the AFRPS through
attendance at an annual face-to-face meeting; active participation in committees, and other
initiatives supporting the AFRPS; responding to violative product samples; and developing and
implementing an auditing program. In addition, under mutual reliance initiatives, the NCAFP will
collaborate with FDA to develop the processes, procedures and systems to integrate state
animal food regulatory work into a nationally integrated food safety system. The outcomes of
this proposal will contribute to state and federal efforts to promote regulatory compliance and
prevent foodborne illnesses.

Public health relevance
Project Narrative Access to a supply of safe animal foods and feed ingredients is a critical element of ensuring a safe human food supply for the world’s population. Utilizing the Animal Food Regulatory Program Standards (AFRPS), the North Carolina Food & Drug Protection Division will further develop the capabilities of their Animal Feed Program (AFP) to ensure the safety of animal foods and feed ingredients manufactured, distributed and/or sold in North Carolina through maintaining full implementation of the AFRPS and participating in mutual reliance initiatives. We will strive to improve the safety and security of the US animal food supply and improve the protection of both human and animal health through this commitment to implement an inspection and enforcement program in partnership with FDA and other state regulatory programs.